Multidisciplinary Investigations in Visual Science

PROJECT SUMMARY
The goal of this National Eye Institute (NEI) P30 competitive renewal is to continue to enhance
the research activities of NEI-funded investigators at The University of Iowa. This will be
achieved by providing a suite of Core Services, performed by skilled technical staff and
supervised by experienced NEI-funded faculty members, employing standardized, automated
procedures when possible. We have modified the Core Services in this renewal application to
continue to provide the most up-to-date state-of-the-art services to meet the evolving needs of
NEI-funded faculty at The University of Iowa. The combination of centralization (allowing
specialization and concomitant increases in efficiency) and the breadth of services available
from the various Cores are expected to continue to provide utility and increased productivity to
all vision researchers at The University of Iowa.
The University of Iowa NEI P30 program is aimed at supporting three primary service cores: 1)
Molecular Imaging Core; 2) Rodent Phenotyping Core; and 3) Bioinformatics and Biostatistics
Core. The capabilities of and research activities provided by these cores all require specialized
equipment and highly trained staff that would be inefficient and costly to duplicate in every
laboratory seeking to employ these techniques.

Public health relevance
PROJECT NARRATIVE The visual sciences research cores have been updated and provide state-of-the-art and centralized research techniques such that work is performed in an efficient and standardized manner without the need to duplicate equipment and highly trained staff. The services available from the cores provide utility and increased productivity to all vision researchers at The University of Iowa.